MT INBRE: A Multidisciplinary Research Network

Project Summary
During the past four years, we have witnessed global challenges of historic proportion. In Montana,
COVID-19 and extreme weather events (including fire and flooding) have irreversibly changed communities
and exposed the fragile status of health and well-being for people already experiencing health disparities. The
MT INBRE network is culturally and economically diverse. Our experience shows that bringing together
engaged community members, researchers from local institutions, and experienced biomedical researchers
can facilitate research that improves health and well-being. The MT INBRE program is particularly important for
Montana because the state does not have a medical school. This program serves as a major driver of health
improvement through research-based interventions.
We believe that Montana communities should drive research questions and contribute to finding solutions
to mitigate the health disparities they experience. Therefore, MT INBRE V will use its well-established network
to further strengthen collaborations among rural and Native communities with tribal colleges, primarily
undergraduate institutions, and research universities. We believe tribal colleges should be conduits for
research on the reservations and primarily undergraduate institutions conduits for rural health research. MT
INBRE V will bring together strengths in bench research, community based participatory research (CBPR), and
healthcare workforce development as a unified front taking aim at health issues critical to Montana and the
Western IDeA states. Our experience shows that building partnerships on a foundation of diverse perspectives
and personal investment leads to measurable outcomes.
MT INBRE V is focused on two main goals: 1) diversify the biomedical/health sciences research network
and student pipeline in Montana, and 2) improve the health of rural, urban and Native Montanans through
sustainable research. MT INBRE V will realize these goals and research targets through a detailed plan for
enhancing diverse perspectives and four specific aims: Specific Aim 1. Build a diverse, equitable, and inclusive
foundation for biomedical research and data science in Montana; Specific Aim 2. Build the state’s research
base and capacity by providing support to faculty, postdoctoral fellows, and graduate students at participating
institutions; Specific Aim 3. Engage students from primarily undergraduate institutions, community colleges,
and tribal colleges in research; and Specific Aim 4. Reduce redundancy, increase interdisciplinary research
collaborations among faculty, and broaden research and education opportunities for students in Western IDeA
states through the Regional Alliance of INBRE Networks (RAIN).

Public health relevance
Project Narrative MT INBRE V will catalyze and strengthen biomedical and health science research across a culturally and economically diverse network by valuing inclusivity and embracing all perspectives. The goal of this program is to use research to address health disparities in rural and tribal communities in Montana.